The spatial and temporal dynamics of neural interactions underlying attention-related enhancement and suppression of visual processing

Attention is critical for filtering incoming sensory information; however, attentional function is often impaired
in common neuropsychiatric disorders including ADHD or schizophrenia. Visuospatial attention in particular
involves both the enhancement of attended information and the suppression of ignored information at locations
across the visual field. Major theories of visuospatial attention propose an interdependent relationship between
enhancement and suppression, arising from competitive interactions between neural populations representing
different visual field locations. Furthermore, recent research demonstrates that visuospatial attention involves
‘rhythmic sampling’ of the environment, with periodic alternation (~4-6 Hz) between two functional states: one
that promotes selective processing at an attended location and another in which attentional selection is
relatively diminished and attentional shifts are more likely. To investigate the neural basis of rhythmic sampling
during visuospatial attention, the proposed research will test the temporal dynamics of enhancement and
suppression-related competitive interactions between neural populations in extrastriate visual cortex (i.e., V4)
representing different visual field locations (Aim 1). The processing of sensory information in visual cortex can
be modulated by top-down control from the frontal eye fields (FEF) and lateral intraparietal area (LIP), two
cortical nodes of large-scale ‘attention network’ that have previously been linked with attention-related
enhancement and suppression. Recently, rhythmic sampling during visuospatial attention has been shown to
involve rhythmic changes in neural activity within FEF and LIP. Emerging evidence points to functional
specialization between FEF and LIP with respect to enhancement and suppression. The proposed research
will further test the temporal dynamics of enhancement and suppression-related functional interactions
between these higher-order cortical areas and visual cortex during the deployment of visuospatial attention
(Aim 2). Multisite laminar probes will be used to simultaneously record neural activity from FEF, LIP, and V4 in
two to three monkeys. In a visuospatial detection task, cues will indicate the locations of upcoming targets
and/or distractors which will be presented within the receptive fields of recorded neural populations. This
approach will reveal the temporal dynamics of network-level interactions supporting enhancement and
suppression across the visual field, including (i) functional interactions between V4 neural populations
representing distinct visual field locations (Aim 1) and (ii) functional interactions between higher-order cortical
areas (i.e., FEF and LIP) and V4 during the voluntary deployment of enhancement and/or suppression (Aim 2).
Results from these complementary, yet independent aims will provide key insights into how visuospatial
attention shapes perception via the enhancement and suppression of sensory processing. The proposed
project could therefore uncover new pathways for therapeutic intervention that could ultimately increase quality
of life for individuals experiencing attentional deficits.

Public health relevance
Attentional impairments are associated with many common neuropsychiatric disorders. Investigation of (i) the neural circuits supporting the attention-related enhancement and suppression of visual sensory processing and (ii) the temporal dynamics of network-level interactions underlying these effects will provide novel insights to guide the development of therapeutic interventions.